DIRECTORS OFFICE, TNPRC

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The Director's Office provides oversight and overall responsibility for the scientific, administrative and operational functions of the Center. The Director, with input from the Executive Committee, faculty and the Scientific Advisory Board, develops and implements the scientific direction and planning for the Center. This includes determining future funding opportunities, long range strategic planning, establishing collaborative agreements with other institutions and representing the Center's interests with our host institution, funding institutions and local community. The Director's Office is also responsible for allocation of resources to the various units at the Center. Administrative and Operational oversight is also provided from the Director's Office with primary responsibility for supervision of Administrative Services, Facilities Services, IT Services, Occupational Health, Communications and Security. Each of these units has a manager who reports to the Director's Office. The major achievements of the last year were 1) completion of several construction/renovation projects and 2) hiring a new Associate Director for Operations and two new faculty and 3) having a record year for overall funding.